NMB STUDY--2AMINOPURINE-CYTOSINE BASE MISPAIRS IN DNA

An investigation into the structural conformations assumed by aberrant base pairs in DNA is proposed. The model system which we intend to study is comprised of a synthetic DNA polymer of known sequence interrupted by a single 2-aminopurine cytosine base mispair. 2-aminopurine, a base analogue of adenine, is a strong mutagen which can replace adenine in DNA and subsequently mispair with cytosine at relatively high frequencies in vivo and in vitro. Our specific objective is to determine if 2-aminopurine cytosine base mispairs in DNA contain either of the two bases as a disfavored imino tautomer, favored amino tautomer, or ionized base. The method proposed to address our objectives is N-15 NMR spectroscopy. The effects of nearest neighbor base stacking partners and changes in solvent conditions will also be investigated. These experiments are directed toward fundamental issues concerning the physical-chemical basis of mutagenesis at a molecular level. The experimental findings should be relevant to the medical areas of cancer, aging and metabolic disorders involving base substitutions in DNA.